Molecular and Functional Taxonomy of Cardiovagal Neurons

PROJECT SUMMARY
Heart rate is one of the most widely used and informative metrics of health. Yet, the neural circuits which
determine heart rate are only partly known. Over a century of research has shown that heart rate is oppositely
controlled by the two branches of the autonomic nervous system, which increase (sympathetic) or decrease
(parasympathetic) heart rate in response to the body’s changing needs for circulation. Parasympathetic input to
the heart occurs through the vagus nerve, a cranial nerve which carries axons from hindbrain parasympathetic
neurons, known as cardiovagal neurons, to downstream neurons in the cardiac ganglia. The vast majority of
cardiovagal neurons reside in the nucleus ambiguus (nAmb) of the hindbrain. However, the nAmb is also home
to a variety of other neurons, which presents significant technical challenges to studying the cardiovagal
subset. For instance, intermingled with the nAmb’s cardiovagal neurons are parasympathetic neurons which
mediate pulmonary function (bronchoconstriction, bronchosecretion) and motor neurons controlling upper
airway and esophageal muscles. The inability to access the cardiovagal subset has greatly limited what we
know about their synaptic circuitry, gene expression, and specific roles in heart function. Thus, there is much to
learn about the nature of these important neurons, how they function, and how they can be targeted to treat
heart disease. To address these issues, our proposal will leverage the molecular diversity of nAmb neurons in
mouse models to comprehensively classify neuron subtypes by their gene expression. Then, utilizing genetic
differences between the nAmb neuron subtypes to gain access, we will trace each subtype’s synaptic inputs
and outputs using viral vectors, and then activate and inactivate each subtype to reveal their specific
physiological roles. Preliminary studies have identified three subtypes of nAmb neurons, one of which
innervates multiple sites in the heart, and shown the feasibility of our approach to mapping and manipulating
specific neural circuits. The results of the proposed studies will define the molecular and functional
organization of the nAmb and yield unprecedented insight into the neurons, neural circuit, and signaling
pathways that control heart rate.

Public health relevance
PROJECT NARRATIVE The parasympathetic nervous system controls heart rate and this is perturbed in many heart diseases, including heart failure, arrhythmia after myocardial infarction, cardiac sudden death, and cardiac autonomic neuropathy (CAN) in diabetes. Parasympathetic control of the heart (e.g., heart rate variability) is a robust indicator of cardiac health and predictor of mortality and morbidity, though the neurobiological basis of this control is only partly known. A better understanding of the parasympathetic cells, circuitry, and signals which control heart rate will reveal novel therapeutic targets and strategies for treating heart diseases.